Core D: Mouse Genetics and Genomics Core

Summary/Abstract
All projects in this program will make extensive use of genetically manipulated mice as the primary
experimental platform. The Mouse Genetics and Genomics Core (Core D) is an essential component of the
Program providing critical support to all 4 projects and to scientific cores B and C. The Core will capitalize on
the infrastructure established at the University of Iowa Gene Editing Facility for the generation of genetically
altered mouse models using CRISPR-Cas9 genome editing and in the Genomics Division of the Iowa Institute
of Human Genetics (IIHG) to support genome wide transcriptome analysis. The goals of the Core are to: 1)
provide centralized breeding, genotyping and quality control of transgenic and knockout animals for use by
investigators in the program project, 2) generate new transgenic mouse models needed during the proposed
budget period for Projects 2 and 4 (and in the future for Project 3), and 3) perform and analyze global
transcriptome studies proposed within Projects 1-4.

Public health relevance
Narrative All projects in this program will make extensive use of genetically manipulated mice as the primary experimental platform. The Mouse Genetics and Genomics Core (Core D) is an essential component of the Program providing critical support to all 4 projects and to scientific cores B and C. The Core will provide support for breeding, genotyping and informatics, and the generation of new mouse models to understand mechanisms of hypertension.